Coordinated responses to host-derived stresses in C. neoformans

SUMMARY
Although potent antifungal agents are currently available, invasive fungal infections remain
highly prevalent causes of disease and death, especially in our most vulnerable patients with defective
immune systems. AIDS, organ transplantation, and more aggressive cancer treatments all contribute to
ever-expanding patient groups who are at risk for these serious infections. Future directions in the
treatment of infectious diseases will increasingly involve identifying microbe-specific cellular processes
that can be targeted for intervention.
In this proposal, we will study central signaling pathways in the human fungal pathogen
Cryptococcus neoformans (Cn) that are induced in the setting of infection. We began studying the
fungal-specific Rim signaling pathway in Cn as a regulator of surface capsule expression and fungal
cell fitness. Using complementary transcriptomic, proteomic, and microbial genetic techniques, we have
defined Rim-dependent cellular events in this fungal pathogen that allow rapid microbial adaptation to
the host environment. Many of these adaptations occur specifically in response to the pH of the infected
host. Therefore, our studies not only address microbial pathogenesis, but they also explore central
ways in which eukaryotic cells sense and respond to this important environmental condition.

Public health relevance
PROJECT NARRATIVE The experiments in this proposal explore ways in which microorganisms adapt to the infected host to favor their own survival. The investigators have identified microbe-specific features that mediate these adaptations, suggesting new targets for antimicrobial therapy. Additionally, these experiments will explore how understanding and intervening with the host response to infection might also contribute to the optimal treatment of infectious diseases.